Efficacy of kTMP, a novel non-invasive brain stimulation method, for the treatment of anhedonia patients.

Project Summary/Abstract
The discovery of more effective treatments for Major Depressive Disorder (MDD) is a pressing clinical demand.
Non-invasive brain stimulation (NIBS) offers a promising treatment for many neurological and psychiatric
disorders. However, to date, the clinical efficacy has proven highly variable. This is likely because current NIBS
approaches cannot precisely modulate patterns of brain activity at intensity levels sufficient to produce
physiological and behavioral change that is clinically relevant.
The goal of this proposal is to test and validate a novel first-in-class non-invasive approach to engage the brain
reward circuitry for treating anhedonia, a core symptom of MDD. We have developed a kilohertz Transcranial
Magnetic Perturbation (kTMP) device, which allows modulating neural activity non-invasively – with no patient
discomfort – at and beyond stimulation intensities associated with significant physiological and behavioral
change, something that is difficult to achieve with existing NIBS methods.
The three-year funding period will be used to assess proof-of-mechanism for the efficacy of kTMP in improving
anhedonia in patients suffering from MDD. We will apply kTMP over the dorsal prefrontal cortex (DLPFC) to
engage deep structures within the reward circuitry that are connected to the DLPFC. Specifically, our goal is to
influence the ventral striatum, a key structure that is associated with anhedonia. Using a novel fMRI-based
neuronavigation approach, we will personalize the precise location within DLPFC to optimize the engagement of
the reward network. We will assess whether kTMP leads to an increase in ventral striatal activation during reward
anticipation (Aim 1) and evaluate if these physiological changes are associated with reduced anhedonia
symptoms (Aim 2). If our expectations are confirmed, our novel NIBS system holds the promise of revolutionizing
the treatment landscape for patients with debilitating anhedonia symptoms, paving the way for a new era of
enhanced recovery and improved quality of life.

Public health relevance
Project Narrative Major Depressive Disorder (MDD) is the leading cause of ill health and disability worldwide, with anhedonia being a core symptom that characterizes the disorder for many individuals. The goal of this proposal is to provide a first assessment of the efficacy of our innovative non-invasive brain stimulation system, kTMP, in the treatment of anhedonia in MDD. kTMP can target frequency-specific neural activity using stimulation intensities that are unattainable with existing methods, all while causing no discomfort to the patient. The results from this work will set the stage for future trials to establish definitive efficacy of kTMP as an intervention for patients with debilitating symptoms of anhedonia.